Octahedral iron coordination cages as T1 MRI probes

Project summary
MRI contrast agents that contain biologically relevant metal ions such as iron are
of interest as alternatives for gadolinium-based contrast agents. Self-assembled Fe(III)
coordination cages are a promising class of compounds for development as T1 MRI
probes. Coordination cages have the advantage of being kinetically robust towards
dissociation in aqueous solution and produce high proton relaxivity from the tightly
connected Fe(III) centers to increase the molecular orientation time in solution. Specific
aims include the preparation of a class of octahedral iron coordination cages containing
acylhydrazone linkages and six high-spin Fe(III) centers. Four derivatives will be prepared
including one with sulfonate or carboxylate substituents on the phenolate groups to
increase the charge and solubility of the complexes. Neutral methoxy-substituents will be
prepared to increase aqueous solubility of the parent octahedral cages without the
addition of charge. Finally, the conjugation of amino acids to the phenolate groups will be
explored as a more advanced and versatile type of derivatization. Longitudinal and
transverse proton relaxation of bulk water will be studied for all new iron coordination
cages which will also be characterized by magnetic susceptibility, mass spectrometry and
x-ray crystallography. Diamagnetic Ga(III) analogs will be prepared to further study the
properties of the cages by using NMR spectroscopy. Binding of the Fe(III) cages to serum
albumins and determination of the mode of binding by relaxivity studies in the presence
of competitive binders will be explored to better understand how to modulate these
interactions. The most promising water-soluble cages will be studied by dynamic
magnetic resonance contrast imaging in mice containing subcutaneous CT26 tumors.
Long-term objectives include the development of this new class of MRI probes that have
versatile scaffolds for functionalization towards tissue targeting and drug encapsulation.

Public health relevance
Project Narrative MRI contrast agents based on iron may be safer alternatives to the gadolinium-based MRI contrast agents that are used in 40% of clinical MRI procedures. Our approach uses coordination cages with multiple tightly connected trivalent iron centers to produce a large signal from a low concentration of agent. Studies proposed here will focus on modifying the iron coordination cage to improve water solubility, biodistribution and clearance in mice models to further develop this new class of contrast agent.